TRIAL OF LOW MOLECULAR WEIGHT HEPARIN TO PREVENT THROMBOSIS

Twenty-seven patients have been accrued to determine whether daily enoxaparin injections will prevent deep vein thrombosis related to venous access devices. Because the study is blinded, result data are not available.